Chronic Inflammation and Type 2 Diabetes: A Multi-omics Approach

ABSTRACT
The etiology of type 2 diabetes (T2D) likely involves a complex interaction of polygenic, metabolic, and
environmental factors including diet. Accumulating experimental, epidemiological, and clinical evidence
supports a pathogenic role of chronic inflammation in T2D development. However, the precise mechanisms
underlying these findings are largely unknown, and current evidence on the causal relationships between
specific inflammatory pathways and T2D risk is inconclusive. Advances in omics technologies have led to
the identification of genes and metabolites associated with T2D risk, but data on mechanisms and causality
are still very limited. Multi-omics integration in the framework of systems epidemiology may provide new
avenues to enhance our understanding of disease mechanisms. To systematically investigate the relation
between chronic inflammation and T2D, I propose to examine 3 Specific Aims by leveraging the rich
resources in the UK Biobank, Nurses’ Health Studies (NHS), Health Professional Follow-up Study (HPFS),
Hispanic Community Health Study/Study of Latinos (SOL), and Genotype-Tissue Expression project
(GTEx). In Aim 1 [K99], I will integrate existing genomic data from the UK Biobank, NHS/HPFS, SOL, and
transcriptomic data in the GTEx to examine shared genetic architectures between systemic inflammatory
markers and T2D and whether polygenic susceptibility to chronic inflammation confers T2D risk. Meanwhile,
I will receive extensive training in T2D systems biology and cutting-edge high-dimensional data analytics
and bioinformatics. In Aim 2 [R00], I will integrate dietary and metabolomic data to examine metabolomic
profiles mediating the association between dietary inflammatory potentials and T2D risk in the prospective
NHS/HPFS and the SOL. In Aim 3 [R00], I will conduct plasma proteomic profiling in a nested case-control
study within the NHS to identify inflammatory protein networks in relation to T2D risk, and as a Secondary
Aim, integrate findings from Aim 1-3 to explore T2D-related pathways co-regulating at multiple biological
dimensions. Findings from this project may improve the understanding of inflammatory mechanisms
underlying T2D and identify novel targets/pathways suitable for early detection and prevention. I will be
mentored/advised by an interdisciplinary team that includes Dr. JoAnn Manson (diabetes epidemiologist),
Dr. Liming Liang (expert in statistical omics methodologies), Dr. Frank Hu (nutritional epidemiologist), Dr.
Peter Kraft, (statistical geneticist), Dr. Qibin Qi (genetic epidemiologist), Dr. Towia Libermann (expert in
proteomics), and Dr. Clary Clish (expert in metabolomics). The outstanding training opportunities with key
leaders in these areas will provide me advanced knowledge and skills, positioning me for a successful,
independent career as a diabetes epidemiologist with expertise in systems biology and integrated-omics.
This project aligns with the NIDDK’s goal of integrating multi-omics technologies into diabetes research.

Public health relevance
PROJECT NARRATIVE This project seeks to systematically examine the relationship between chronic inflammation and type 2 diabetes (T2D) by incorporating multi-omics data from several large prospective cohort studies. The proposed research will yield novel evidence on the biological mechanisms underlying the relationship between chronic inflammation and T2D risk. Novel pathways, and specific genes, proteins, and metabolites identified in this research will serve as the critical first steps for future development of biomarkers and therapeutic targets for T2D prevention and treatment.